Development of implementation toolkits to promote HPV self-sampling behavior among Women Living with HIV in Ghana

ABSTRACT
Women living with HIV, (WLWH), in low- and middle-income countries (LMICs) have a six-fold increased risk of
developing cervical cancer (CC) compared to their uninfected counterparts. Our studies in Ghana show that self-
sampling is acceptable, easy to use, and efficacious in detecting precancer lesions among WLWH. However,
this screening mechanism has not been translated to healthcare practice in Ghana.
Systematic adaptation and implementation toolkits are needed to translate self-sampling into healthcare
practices. We develop a Home-based self-collected sampling for the cervical cancer Prevention Education
(HOPE) toolkits to promote cervical cancer screening in Ghana. HOPE toolkit core components such as (a) self-
sample HPV testing kits and (b) the 3R (Reframe, Reprioritize, and Reform) communication model will not
change as they are evidence-based. The content and the intervention delivery modalities of HOPE will go through
the cultural adaptation iterative processes.
This R21 resubmission seeks to develop contextually appropriate adaptation and implementation toolkits in
Ghana. A three-step approach will be used for the adaption process and evaluation of the toolkit. First, we will
organize focus group discussions to identify contextual factors affecting the toolkit adaptation and nominal group
techniques to determine the different compositions of the toolkits and select the final toolkit. A sample of 35
stakeholder advisory board members representing three organizational levels: potential intervention participants
(i.e., WLWH), community leaders, and healthcare workers (e.g., doctors, nurses, administrators) will participate
in the FGDs and NGTs. Second, we will recruit 45 participants including WLWH and healthcare workers to
evaluate the feasibility, acceptability, appropriateness, and adoptability of the selected toolkit. Third, we will test
the preliminary efficacy of HOPE on cervical cancer screening defined as cervical cancer screening uptake
among WLWH in the intervention arm (n=54) and control arm (n = 54). Participants will be recruited from the
Cape Coast Teaching Hospital (CCTH). Specific aims of HOPE are:
Aim I: Develop and adapt the HOPE toolkit: Hypothesis: Stakeholders will identify and prioritize community
needs and translate findings into a culturally adapted toolkit. Aim II: Evaluate the characteristics of the HOPE
toolkit: Hypothesis: We hypothesize that 80% of participants will find HOPE toolkits feasible, acceptable,
appropriate, and adoptable. Aim III: Assess the efficacy of HOPE on CCS. Hypothesis: We hypothesize that
CCS behavior will increase significantly among women in the intervention group compared to those in the control
group. Aim IV: Identify actionable factors and implementation costs that influence the adoption of the toolkit.
Hypothesis: The Actionable factors and implementation costs will significantly influence the toolkit adoption.

Public health relevance
PROJECT NARRATIVE Population-based cervical screening including self-collect cervicovaginal samples (SCCS) has resulted in reducing the cervical cancer burden in high-income countries and SCCS can help minimize the cervical cancer burden among women living with HIV (WLWH) in Ghana. However, the implementation and dissemination mechanisms to translate SCCS into Ghana’s healthcare systems have not been developed. This proposal seeks to develop contextually appropriate adaptation and implementation toolkits to enhance the adoption of SCCS in healthcare practices in Ghana, increase CCS, and reduce the CC burden.